Estimates of Resident Population for Counties

"To develop the following three products of estimates of resident population for counties:

1.Vintage 2024 estimates (based on old proportions) - county population estimates by
single year of age (0-84) and 85+ (summed), sex, bridged race, and Hispanic origin for
April 1, 2020 (estimates base) and annually July 1, 2020-2024

2.2010-2020 Intercensal Estimates (based on old proportions) - county population
estimates by single year of age (0-84) and 85+ (summed), sex, bridged race, and
Hispanic origin for April 1, 2010 (estimates base); annually July 1, 2010-2019; and April1,2020 (2020 Census)

3.2000-2010 Intercensal Estimates - county population estimates by single year of age(0-84) and 85+ (summed), sex, race alone or in combination, and Hispanic origin for April 1, 2000 (estimates base); annually July 1, 2000-2009; and April 1, 2010 (2010Census)"